A Contrast-free Ultrasound-based Quantitative Angio Flow Imaging Technique to Assess Peripheral Arterial Disease of Lower Limb

Abstract/Summary
PAD is characterized by impaired blood flow to the lower extremities, causing claudication and exercise
intolerance. Up to now, assessment of PAD is mainly performed by determination of stenosis or occlusion in
the large arteries and does not focus on microcirculation. Impaired arteriolar endothelial function,
microvascular responsiveness to specific stimuli in patients with PAD may play a central role in disease
development and progression. The impaired microvascular reactivity can be assessed by hyperemic
response to contraction and cuff occlusion as well as in response to submaximal exercise. Therefore, imaging
microvascular flow reactivity at various scales using methods that are safe, noninvasive, reliably quantitative,
and low-cost through application of already widely available technology is critically important for early
diagnosis and management of PAD. Here, we propose a novel contrast-free ultrasound pressure-based
method equipped with novel quantitative metrics that involves estimation of blood flow signals in the calf
muscle through processing ultrasound data frames by means of coherent ensemble selection, clutter filtering
using singular value decomposition, and background noise equalization, followed by quantitative analysis of
the flow variations in response to external pressure and submaximal exercise. Our vision is to complement
US with additional quantitative information of microvascular flow imaging that is relevant to disease
progression. Our long-term goal is to develop a new noninvasive tool for early diagnosis of PAD. A
secondary gain from such an imaging method will be monitoring the disease progression and the response
to interventional treatment in PAD patients. The proposed contrast-free ultrasound-based technique is named
Angio Flow Reactivity Analysis (AFRA). An advantage of this technique is that it does not require the use of
contrast agents to produce high-resolution images of the microvasculature flow. The project includes 2
specific aims: Specific Aim 1- Determine the efficacy of the new contrast-free US-based method, AFRA, for
assessment of PAD in patient volunteers with symptoms of claudication or atypical leg syndrome and
correlate the results with ABI and CTA. Specific Aim #2- Determine the efficacy of the proposed contrast-free
US-based method, AFRA, for assessment of disease progression and monitoring the response to
interventional treatment in patients diagnosed with PAD and correlate and the results with ABI and CTA. This
proposal is the result of collaboration among several experts in the field and benefits from the world-class
clinical researchers and facilities at Mayo Clinic. The overall project aims to develop a new contrast-free
ultrasound tool for evaluating microvascular flow changes in the lower leg of patients at risk for PAD, a
disease that leads to common disabilities, amputation, and major cardiovascular events. Successful
completion of this research will open the door for a new technology for this group of patients in the clinic.

Public health relevance
Public Health Relevance Statement The goal of this project is to develop a new low cost, noninvasive ultrasound-based tool for imaging microvascular changes associated with peripheral arterial diseases. Specifically, the new method will have a significant impact on early detection as well as assessment of disease progression and the response to therapy.